Amadorins for Ameliorating Alzheimer's Disease and Related Dementias (ADRD)

PROJECT SUMMARY
Alzheimer’s Disease (AD) is recognized as a major public health issue that is projected to worsen in the aging
U.S. population — the number of people of age 65 and older in the U.S. will reach 88 million by 2050. However,
despite intensive efforts, there is an absence of sufficiently effective therapeutic options. AGE formation is an
established pathogenic factor in AD progression, impacting putative pathogenic mechanisms involving both
amyloid beta and tau. Brains are replete with glucose and ascorbate, both of which fuel AGE formation. AGE
formation is also an oxidative chemical reaction requiring redox metal ion catalysis, and it is known that AD
progression leads to brain accumulation of pro-oxidant copper and iron. These AGE accelerants generate free
radicals and reactive oxygen species (ROS) that are independently causative of neuronal damage. Our
hypothesis is that a drug candidate that: (1) is brain penetrant, (2) inhibits AGE formation and (3) reduces
oxidation by redox metal ions will exhibit efficacy in treating AD/ADRD. We advance in this proposal the novel
“Amadorin” drug candidate PTG-630, a potent inhibitor of advanced glycation end products (AGEs) that also has
the dual potential as an antioxidant due to its excellent binding of redox metal ions, particularly Cu2+. We recently
discovered that PTG-630 prevents mild cognitive impairment in diabetic rats and in a transgenic mouse model
of AD when treatment was begun at onset of disease. We now propose to evaluate the therapeutic potential of
PTG-630 in reversing established cognitive dysfunction and neurodegeneration in multiple animal models of AD,
as this is the most likely scenario for clinical use of a therapeutic agent. We plan to achieve our goals through
two specific aims: (1) Test the efficacy of PTG-630 against central nervous system (CNS) dysfunction in an
intervention paradigm; and (2) complete safety assessments of PTG-630 tri-HCl and initiate PK and safety
studies in dog in preparation for pre-IND requirements. To mirror the most likely clinical use as an AD/ADRD
therapeutic, we will start treatment with PTG-630 only when CNS dysfunctions are established. Studies will be
performed using a suite of established mouse models of AD, namely mice overexpressing a) human non-mutant
tau (htau), b) a mutant form of APP (Tg2567) or c) a triple transgenic (3xTg) model overexpressing mutant APP,
mutant tau and mutant presenilin. We will also evaluate the ability of PTG-630 to reverse established loss of
corneal nerves in the mouse models of AD, exploring whether corneal neuropathy can serve as a novel
biomarker for early AD that will predict efficacy of intervention against CNS dysfunction. For Specific Aim 2, we
will carry out non-GLP studies through pharmacokinetics, metabolism, and pharm-tox screening. We will also
initiate dog safety and pharmacology studies. Praetego’s Amadorin PTG-630 is expected to offer a disease
modifying breakthrough against AD/ADRD. Successful completion of this project will establish efficacy in
reversing ADRD and provide sufficient experimental data to support a pre-IND FDA meeting towards therapeutic
translation to humans.

Public health relevance
PROJECT NARRATIVE Alzheimer’s Disease (AD) is recognized as a major public health issue that is projected to worsen in the aging U.S. population — the number of people of age 65 and older in the U.S. will reach 88 million by 2050. There is an absence of sufficiently effective therapeutic drugs that can delay the onset or prevent disease progression. This would have enormous benefits, both to patients and to our economically burdened health systems. Based on our recent preclinical findings, Praetego intends to advance their novel drug candidate PTG-630 as a disease modifying therapeutic with potential to impact onset or progression of AD and its related dementia (AD/ADRD).